Aberrant Cardiolipin Dynamics in Barth Syndrome

Project Summary/Abstract Mitochondria are membrane-rich organelles that are essential to eukaryotic life. Detailed insight has emerged into the assembly and the dynamics of mitochondrial membrane proteins, but a fundamental gap has remained in understanding mitochondrial lipids. Barth syndrome (BS) is a disorder of the mitochondrial lipid metabolism, in particular the metabolism of the mitochondria-specific phospholipid cardiolipin (CL), and thus provides a unique opportunity to address this gap in a context relevant to human health. BS is caused by mutations in tafazzin, an enzyme that catalyzes CL remodeling, i.e. the fatty acid exchange reaction by which the characteristic molecular composition of CL is created. The objective of this application is to identify mechanism and function of CL remodeling. This objective fits into our broad goals to understand the function of CL in mitochondria and to unravel the molecular pathophysiology of BS. We discovered that the global assembly of the system of oxidative phosphorylation (OXPHOS) is driving CL remodeling. We hypothesize that CL remodeling reduces the packing stress imposed on mitochondrial lipids by the extremely high protein concentration, which arises in mitochondrial membranes due to the OXPHOS system and other proteins. Thus, the function of CL remodeling is to stabilize lipid-protein interactions in order to allow the assembly of protein- crowded membranes. To test this hypothesis, we will (i) identify the mechanism by which OXPHOS expression controls CL remodeling and (ii) establish the function of CL remodeling in membrane assembly. First, in order to identify the mechanism by which OXPHOS expression controls CL remodeling, we will determine the effect of OXPHOS assembly on the CL remodeling reaction, then identify the OXPHOS assembly step that is critical for CL remodeling, and finally determine whether protein crowding affects CL remodeling. Second, in order to establish the function of CL remodeling, we will determine the effect of CL remodeling on the density of OXPHOS complexes, on the stability of cristae membranes, and on the development of germ cell mitochondria. Germ cell mitochondria will be studied because our preliminary data suggest a specific role of CL remodeling and OXPHOS assembly in spermatogenesis. Experiments will be carried out in genetically modified yeast, Drosophila, and mice. Our application relies on cutting-edge techniques, such as lipidome- wide flux analysis with stable isotopes, cryo-electron microscopic tomography, and quantitative proteomics. The proposed study is significant because it will identify the mechanism and the function of CL remodeling, a widely conserved reaction of uncertain significance, and because it will establish the pathologic mechanism of BS.

Public health relevance
Project Narrative The proposed project is relevant to public health because it will elucidate the underlying cause of Barth syndrome, a mitochondrial disease affecting multiple organ systems. The work will provide critical insight into the role of mitochondria in energy metabolism and germ cell development. Such results will support the NIH’s mission to develop fundamental knowledge that will help to reduce the burden of human disability.